Disease Mechanisms at the Intersection of Glaucoma and Alzheimer's Disease

Project Summary / Abstract: Alzheimer’s disease (AD) and glaucoma are two of the most prevalent age-related neurodegenerative disorders recognized worldwide. Globally, AD is the most widespread cause of dementia and a substantial cause of death, while glaucoma is the leading cause of irreversible blindness. In glaucoma, a characteristic optic neuropathy is associated with progressive visual field defects. There is currently no cure for either disease, although treatments that lower intraocular pressure can slow progression of vision loss glaucoma. In AD patients, characteristic neuropathologic changes in the brain include amyloid beta (Aβ) plaques and neurofibrillary tangles composed of hyperphosphorylated tau. Aβ and tau have also been observed within the optic nerve (ON) and retina of both AD patients and glaucoma patients. Other shared disease features include microglial activation and progressive neurodegeneration, which in glaucoma primarily affects RGCs and their axons in the ON. AD patients are 2-3 times more likely to develop glaucoma than those without AD. Epidemiologic studies have also examined the risk for glaucoma patients to develop AD and have identified associations that are not attributable to age alone, or to medications. Together, these findings indicate the potential for shared or synergistic mechanisms responsible for, or contributing to, both diseases. Potential mechanisms include, but are not limited to, microglial activation, protein aggregation and mislocalization, and impaired dendritic and synaptic inputs. We hypothesize that glaucoma and AD act synergistically to intensify neuroinflammation, AD- like pathology, and neurodegeneration, accelerating progression and functional decline in both diseases. However, it is challenging to elucidate mechanisms for this observed shared risk for glaucoma and AD in older human populations with other age-associated co-morbidities. Given the profound cumulative negative impact of both diseases on the health of the aging population, and lack of effective therapies, there is an urgent need for improved understanding of the interaction of glaucoma and AD. To address our central hypothesis, the proposed studies will interrogate the histologic, transcriptomic and protein expression changes in specific eye and brain regions over the course of disease progression in two complementary models of glaucoma (optic nerve crush and ocular hypertension induced by intraocular microbead injection) in mice with normal and AD transgenic backgrounds, relating these neuropathologic changes to rate of functional decline in memory, cognition and vision. Success in these studies will provide mechanistic insight into the interaction between AD and glaucoma, illuminating and prioritizing shared and novel targets to inform the development of new therapeutic strategies to slow disease progression and enhance quality of life in AD and glaucoma patients.

Public health relevance
Public Health Relevance/Narrative Alzheimer’s disease (AD) causes relentlessly progressive dementia and affects an estimated 1 in 8 Americans over the age of 65, while glaucoma is the leading cause of irreversible vision loss. Patients with AD are at significantly higher risk of developing glaucoma, further negatively impacting their quality of life and potentially accelerating progression of dementia. This project will examine the effect of glaucoma on progression of AD pathology in the eye and brain and will provide critically needed information on the interaction between these two age-related diseases that could profoundly impact clinical management strategies for both AD and glaucoma patients.